Louisiana Clinical and Translational Science Center

Project Summary: Overall
The Louisiana Clinical and Translational Science (LA CaTS) Center is a consortium of the major academic
and biomedical research centers in the State of Louisiana. Pennington Biomedical Research Center is the lead
institution and will continue to partner with Louisiana State University Health (LSUH)-New Orleans and Tulane
University Health Sciences Center in this initiative. LSUH-Shreveport, LSU-A&M (Baton Rouge), Xavier
University and Children's Hospital New Orleans, were early Research Partners in cycle 1. Southeast Louisiana
Veterans Healthcare System, a newly opened University Medical Center in New Orleans ($1 billion State
investment), Ochsner Health and the LSUH-NO School of Dentistry joined during cycle 2. The LA CaTS Center
is growing a unified clinical translational science program for Louisiana based on the creation of synergistic
programs and unparalleled collaboration from all the major academic and biomedical research institutions in the
state. Since inception 9 years ago, the LA CaTS Center has: 1) successfully leveraged resources and expertise
of multiple participating institutions to build a vibrant statewide research infrastructure; 2) developed highly
synergistic and integrative collaborative programs; 3) implemented a systematic approach to clinical research
across all institutions, that includes a new SMART IRB Reliance Model review; and 4) implemented a highly
effective governance system based on an unprecedented level of trust between partners. LA CaTS is
experiencing exponential growth in research productivity as assessed by key metrics including a three-fold
increase in external grant awards, a more than two-fold increase in publications with authors acknowledging LA
CaTS Center resources and services and over 600 researchers benefiting from and using our services. Notably,
during a period that has been marked by unique and unprecedented challenges from COVID and then Hurricane
Ida, LA CaTS has achieved, and in many cases exceeded, its stated objectives and projected milestones.
Indeed, since the COVID pandemic hit Louisiana in March of 2020, LA CaTS has led multiple successful grant
applications for Administrative Supplements and NOSI awards, notably to facilitate COVID testing and
vaccinations in underserved Black communities through the RADx-UP program and most recently our
partnership with the IDeA state ISCORE consortium on the national Long-COVID initiative - Post-Acute Sequelae
of SARS-CoV-2 Infection (PASC)/RECOVER trial. However, we fully recognize that our work has only just
begun, as we collectively address disparities and improve the lives of our citizens. It is also apparent, that slowly,
but surely, we are impacting public health one project at a time! With new services proposed and the additional
resources that will be added, our Center is uniquely positioned to devote our activities and resources to our major
theme for the next 5-year cycle that will “address health disparities and improve the health outcomes of the
citizens we serve”.

Public health relevance
Project Narrative: Overall Louisiana is in the highest decile for mortality from chronic diseases. The Louisiana Clinical and Translational Research (LA CaTS) Center is an IDeA-CTR dedicated to resolving this devastating health burden by training and promoting clinical and translational research that addresses health disparities and focuses on improving health outcomes in our state. Major areas of research include obesity, diabetes, cardiovascular disease, cancer, and COVID-19, particularly in underrepresented minority and underserved communities.